Multidisciplinary Research Training in Pulmonary Medicine

PROJECT SUMMARY
This proposal describes our research training program in the Division of Pulmonary and Critical Care Medicine
(PCCM) at OHSU. In this program, we offer a multidisciplinary approach to pulmonary research and medicine
that integrates state-of-the-art basic science, clinical trials, and patient outcomes research. Three postdoctoral
fellows (MD or PhD) and three graduate students will be offered one and possibly two years of research
funding.
Research will be supplemented by trainee participation in program-wide research seminars, journal clubs, and
didactic coursework. It is our belief that such program-wide meetings and interactions are vital to providing
young scientists with a broad perspective on research outside their own projects, avoiding early
overspecialization and an inappropriately narrow research focus.
Coursework includes a program-specific course on pulmonary disease and research, Perspectives in
Pulmonary Medicine. We will also offer a wide range of courses appropriate to trainees embarking on a
research career. These include experimental design, grant writing, manuscript writing, human investigations,
epidemiological methods, and career development. These are offered in our graduate programs, our OCTRI
Human Investigations Program, and other University departments.
Research mentorship is provided by a faculty of seasoned scientists with extensive experience in training
young scientists. About half the faculty conducts research primarily involving the lung. The remainder have
specific areas of expertise in cell and molecular biology that are frequently applied to the study of lung
diseases. Interactions and synergy among the laboratories in this program add to the rich and broad training
environment. Our trainees have been very successful given the relative youth of our training program, including
achieving independent research funding, faculty or industry positions in biomedical research, and postdoctoral
positions at other prestigious institutions.

Public health relevance
PROJECT NARRATIVE Lung diseases such as asthma, chronic bronchitis, cystic fibrosis, tuberculosis, emphysema, acute respiratory distress syndrome, and lung cancer cause substantial morbidity and mortality. This program will produce clinical and basic science investigators with broad experience in Pulmonary investigation. The training program will prepare these researchers for the challenges of academic medicine and biomedical research and will help fill the need for the next generation of scientists.